HazMat Risk Management, Readiness and Training Platform

PROJECT SUMMARY/ABSTRACT
HazMat Risk Management, Readiness and Training Platform
A unique aspect of hazardous material incidents is that they affect stakeholders in the community with different
roles and priorities. Workers in facilities who regularly use or handle hazardous materials, transportation
carriers, neighboring communities, first responders, and first receivers (health care workers) are all at risk of
health impacts from hazardous materials. Communities can increase their resilience to a hazardous materials
incident in several ways, including reducing the likelihood of a release, being prepared to respond to a potential
release, and effectively responding if a release does occur. We believe technology advancements and new
training strategies can better equip communities for risk reduction and the rapid and effective response to
incidents. The technology advancements proposed will collectively cover the HazMat risk life cycle from a
facilities prevention and risk management perspective, a first responders pre-planning specific to risks in their
community and a HazMat Incident Command training platform.

Public health relevance
PROJECT NARRATIVE The proposed research aims to improve the first responder worker health and safety by advancing technologies enabling HazMat pre-planning with one or more what if scenarios that consider response, containment and protection of health and life integrated with a virtual trainer allowing for practice of the first arriving unit and HazMat team. The pre-plan and better readiness/trained responders has benefits at the community level and the business owner/workers at a facility with HazMat.